Amplifier Replacement for Slice Electrophysiology Studies

Project Summary The supplemental activities will not change the project summary of the parent award.

Public health relevance
Narrative The supplemental activities will not change the narrative of the parent award.